CD147-CAR-NK Cells for Hepatocellular Carcinoma Treatment

Project Summary: This project will pursue an ‘off-the-shelf’ immunotherapy liver cancer “living drug” by re-
engineering human primary Natural killer (NK) cells derived from a third-party cord blood or peripheral blood to
home-in on a specific hepatocellular carcinoma cancer antigen (CD147). Recent clinical trials testing
cancer immunotherapies have shown promising results for the treatment of various cancers. One such therapy
involves engineering immune cells to express chimeric antigen receptors (CAR), which combine tumor antigen
specificity with immune cell activation in a single receptor. The adoptive transfer of these CAR-modified
immune cells (especially T cells, CAR T) into patients has shown remarkable success in treating multiple
refractory blood cancers. However, CAR T therapy is often associated with significant toxicity, high cost,
marginal effects on solid tumors. In order to achieve the promise of CAR cell therapy in treating solid tumor
cancers, further advances will be required. One key challenge is identifying a safe and effective solid tumor
antigen, as well as development of ‘off-the-shelf’ cell products. We recently devised a novel strategy for
targeting hepatocellular carcinoma (HCC, one of the deadliest solid tumor cancers in humans). We report that
T and NK cells transduced with a CAR that targets the HCC surface marker, CD147, also known as Basigin
(BSG) or extracellular matrix metalloproteinase inducer (EMMPRIN), can effectively kill multiple malignant
HCC cell lines (including SK-Hep1 and HepG2 cell lines), primary HCC in vitro and tumors in xenograft and
patient-derived xenograft (PDX) mouse models of liver cancer (Tseng, HC., D. et al., Nature
Communications., 2020,). Critical gaps in our current knowledge of this immunotherapeutic strategy
include the exact mechanism(s) by which the CD147-CAR-NK cells derived from a third-party peripheral or
cord blood (CD147-CAR-NKprimary) can control HCC and whether the CD147-CAR-NK cells are safe in vivo. We
propose to test the hypothesis that the CD147-CAR-NKprimary targeting HCC is effective and safe. The long-
term goal of this project is to develop a novel immunotherapeutic strategy for the treatment of HCC. The
objective of this application is to assess the efficacy CD147-CAR-NKprimary in vitro using HCC cell lines and in
vivo using a newly created human CD147 transgenic (hCD147TG) mouse model. The proposed work will
characterize the biology of CD147-CAR-NKprimary by analyzing surface marker profile, cytokine production, and
cellular proliferation (Aim 1), test the efficacy of CD147-CAR-NKprimary both in vitro and in vivo (including severe
combined immunodeficiency [SCID], patient-derived xenograft (PDX), and DEN/PB and HDF-induced
orthotopic HCC in hCD147TG mouse model) and investigate the molecular mechanisms with a focus on
immunological synapse (Aim 2), Future plan includes characterization of the CD147-CAR-NKprimary toxicity in
the hCD147TG HCC mouse model. The results of these studies will streamline the path to clinical trials of ‘off-
the-shelf’ CD147-CAR-NKprimary cells for adoptive cell therapy for the treatment of HCC.

Public health relevance
Project Narrative Cancer immunotherapy (isolating a patient’s own T cells, engineering them to express chimeric antigen receptors (CAR) that recognize tumor proteins, and re-infusing them back into the patient) is a promising treatment option for many types of cancer. This proposal pioneers the use of ‘off-the-shelf’ CD147-CAR- NKprimary cells to treat hepatocellular carcinoma (HCC) (among the deadliest of solid tumor cancers) and with the long-term goal of developing safe and effective immunotherapies for HCC.